STUDY OF CONTROLLED RELEASE DARIFENACINE IN TREATMENT OF IBS

The main objective of this study is to evaluate the clinical efficacy, safety and tolerance of controlled release (CR) darifenacin in the treatment of irritable bowel syndrome.